ESTROGEN REPLACEMENT IN PATIENTS WITH ALZHEIMERS DISEASE

To determine whether hysterectomized female patients with Alzheimer's disease who take estrogen replacement therapy show improvement or stability during or after 12 months of therapy.